Establishing Reference Values and Clinical Decision Points for Quantitative Videofluoroscopic Measures of Swallowing

Project Summary/Abstract
Dysphagia (swallowing impairment) is a serious health condition seen in many age-related disease and injury
processes. Although videofluoroscopy (VF) is an international “gold standard” dysphagia diagnostic exam,
there is a paucity of available normative physiologic VF reference values in healthy adults across the age span
to guide interpretation of this examination. This fundamental gap in knowledge contributes to poor agreement
in the identification of swallowing impairment and its underlying mechanisms. To enable better dysphagia
diagnostics, there is a critical need to establish reference values for VF swallowing measures across the healthy
age span. In our previous R01 (DC011020), we developed a rigorous method for measuring swallowing
physiology from VF: the Analysis of Swallowing Physiology: Events, Kinematics and Timing (ASPEKT
Method). We published initial ASPEKT reference values from 40 young healthy adults (<60 years) and
performed preliminary analyses to compare data from healthy older adults and small cohorts of adults with
dysphagia to these reference data. Through this renewal application, we will validate the ASPEKT Method
healthy reference values for swallowing across the adult life span, demonstrate scalability of the ASPEKT
Method across commonly used variations in clinical VF testing protocols, and profile swallowing
pathophysiology in clinical groups where dysphagia is a cause of morbidity to identify clinical decision points
that can be used for diagnosis and outcome measurement. Our vision is that the ASPEKT Method will enable
clinicians to compare patient measures to healthy reference values, facilitating quantification and evidence-
based interpretation of the presence, nature and severity of swallowing impairment. Ultimately, we seek to
generate data that will shift subjective dysphagia diagnostic practices toward a quantitative, evidence-based
diagnostic framework that will improve resource utilization, treatment planning and patient outcomes.

Public health relevance
Project Narrative Dysphagia (swallowing impairment) is a serious health condition seen in many age-related disease and injury processes. Although videofluoroscopy (VF) is an international “gold standard” dysphagia diagnostic exam, there is a paucity of available normative physiologic VF reference values in healthy adults across the age span to guide interpretation of these examinations. We propose to extend our prior work on the quantitative measurement of swallowing physiology from VF examinations to establish reference values for swallowing in healthy adults, and to identify clinical decision point values for differentiating healthy swallowing across the age span from disordered swallowing in several high-risk clinical populations to study dysphagia.